INTELLECTUAL PROPERTY CONSULTING SERVICES

The purpose of this contract is to provide Program with consulting services (e.g., opinions) for the betterment of a given contraceptive research program. The services are responsive to a need identified by the Contraception Research Branch (CRB) to review intellectual property related materials and make informed decisions on identified funded research (e.g., grants and/or contracts). Current staff in CRB do not possess the prerequisite skill set to provide a response on such matters.